RETROSPECTIVE QUALITY ASSESSMENT OF FMRI DATA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Functional magnetic resonance imaging (fMRI) is a specialized application of MRI which places additional demands on scanner performance and stability compared to routine clinical studies. Since fMRI attempts to identify brain regions activated in the presence of particular stimuli or tasks, instabilities or excessive noise in the MRI signal can lead to either false positive or negative detection of activation. When applied to group comparisons as is commonly the case in the study of disease or pharmacological interventions, changes in data quality over time can be misinterpreted as differences between groups. The requirements for fMRI generally exceed the specifications covered by commercial manufacturer quality assessment (QA) and preventative maintenance.